Development and Evaluation of an Instrument to Measure Shared Decision-Making in Pediatrics

PROJECT SUMMARY
Shared decision-making (SDM) is an active process of clinician and patient interaction that is intended to
produce a joint decision. Critical to the implementation of SDM and the evaluation of its effect on health
outcomes is the availability of valid and reliable instruments to measure SDM. Though several instruments
have been designed to measure the process of arriving at a shared decision in the clinical encounter, few have
been deemed high quality and none have been specifically designed to measure the process of SDM in
pediatrics. Furthermore, most instruments measure the SDM process from a singular perspective (e.g., patient
self-report or observer) despite increasing recognition that clinician perspectives are also needed to accurately
capture the dyadic interaction and inherently bidirectional process of SDM.
The primary goal of this project is to develop and evaluate a dyadic instrument to measure the process of
SDM with parents of young children that includes both parent and clinician perspectives. We will anchor the
development of this instrument to a 4-step process for implementing SDM in pediatrics that we developed and
validated in preliminary work using a diverse set of decision-making scenarios across multiple pediatric
disciplines and varied clinical settings. The first 3 steps of this process involve recognition of [>1] medically
reasonable option (Step 1); clinician assessment of the medical benefit-burden ratios of options (Step 2); and
parent expression of preferences regarding options (Step 3). Step 4 encourages a parent- or clinician-guided
SDM based on Steps 1-3 that can be further modified based on the presence of other decisional features.
Our specific aims are to (1) develop a dyadic instrument for measuring the SDM process with parents
of young children using a standard, iterative process that includes item generation, augmentation of the item
pool, item reduction through expert review, and pretesting with parents and clinicians, with a sub-aim to
develop an observer-coded version of the instrument to explore its correlation with the final dyadic instrument
in Aim 3; (2) assess the [internal consistency], construct validity and reliability of the preliminary dyadic
instrument in a controlled, simulated setting by conducting an online experiment in which [parent (N=600)
and clinician (N=600) participants] complete our preliminary dyadic instrument after being randomized to view
one of 4 different pairs of standardized video vignettes that portray a high-quality and low-quality SDM
encounter of a unique decision in pediatrics; and (3) evaluate the construct validity and feasibility of the
final dyadic instrument in the clinical setting by administering the instrument to parent and clinician
participants after [problem-based encounters (N=127)] across a range of pediatric settings and specialties at
two pediatric institutions, [with a sub-aim to develop a Spanish version of the final dyadic instrument.]
This R01 application will yield a valid and reliable instrument to feasibly measure the process of SDM with
parents of young children and will enable follow-on evaluation of SDM on child health outcomes.

Public health relevance
PROJECT NARRATIVE Shared decision-making (SDM) ensures that clinical decisions without a single best choice incorporate and reflect patient preferences, thereby promoting patient empowerment, improving transparency, and increasing trust. There are no instruments specifically designed to measure the process of SDM in pediatrics, limiting the evaluation of SDM on health outcomes in this population. The overall goal of this project is to develop and evaluate an instrument to measure the process of SDM with parents of young children.